Beyond ganglion cells: Novel foveal avascular zone features in MS with implications for vision loss

PROJECT SUMMARY
Multiple sclerosis (MS) is a devastating neuro-degenerative disease that causes visual impairment in young, middle aged
and older adults with resulting substantial lost productivity and cost to society. Current thinking attributes vision loss in
MS to death and dysfunction of the retinal ganglion cells (RGCs) that comprise the optic nerve. However, there is only
weak correlation between visual function and RGC atrophy, and some patients without RGC atrophy have vision loss,
suggesting that all relevant contributors to vision loss in MS have not been identified. We have discovered structural
features in the foveal avascular zone (FAZ) of retinas of the majority people with MS and a minority of people with
glaucoma that cast a shadow on the photoreceptor layer and correlate with visual function. Our discovery contributes to
addressing gaps in understanding visual pathway involvement in MS, offering new windows into diagnosis and treatment
of vision loss in MS. This project studies the recently discovered FAZ features in retinas of people with MS and related
diseases using adaptive optics scanning light ophthalmoscopy, a high resolution, non-invasive, state-of-the-art imaging
technique. In the first aim, the relationship between central visual function and FAZ features will be defined using MS as
an experimental model. Advanced microperimetry will be used to test the hypothesis that photoreceptor shadowing is
the mechanism of vision loss. In the second aim the cause and composition of the FAZ features will be inferred through
longitudinal studies of people with MS, cross sectional comparison between MS, glaucoma and related neurological and
ophthalmic diseases and histopathological study of ex-vivo MS eyes. In the third aim rapid imaging protocols will be
developed to enable faster detection of FAZ features and these will be applied to estimate the distributions of FAZ features
in the populations with MS, glaucoma, other diseases and controls. These observations will evaluate the candidacy of the
FAZ features as biomarkers of MS by defining specificity. The immediate impact of this research will be advancing
understanding of vision loss in MS, developing rapid imaging strategies to enable broader study of large sample sizes at
multiple sites and evaluating FAZ features as biomarkers in MS, glaucoma and other disease.

Public health relevance
Project Narrative Multiple sclerosis, a neurological disease affecting the brain and spinal cord, also impacts the eyes, causing visual impairment and decreasing quality of life. Through study of newly discovered changes in the eyes of people with and without multiple sclerosis this work will establish how this, and other neurodegenerative diseases cause visual impairment. We will also develop objective and non-invasive measures of eye structure that will help treating physicians predict clinical progression and treat visual symptoms in affected people. Furthermore, this work will develop retinal imaging techniques that simplify detection of structural and functional changes that will be applicable to the study of more patients with more diseases, and by more physicians and researchers.